Fox COBRE Phase II Admin Core

Project Summary
Administrative Core
This Phase II COBRE will continue our center’s work to develop molecular approaches for probing biology, to
discover and apply new chemical biology tools for the study of biological pathways associated with disease, and
to develop computational approaches for understanding small molecule interactions with complex
macromolecular targets. Building on the infrastructure and successes of Phase I, our COBRE will develop new
chemical biology tools for understanding the cellular and molecular mechanisms that bacterial pathogens use to
survive and replicate inside host cells, molecular probes that can be used to understand Clp protease targets of
infectious diseases, tools to map and understand the regulation of reversible mRNA modification by a ‘methyl
eraser’ enzyme linked to the progression of human cancers, molecularly-defined nanoparticle adjuvants that
yield specific immune responses in the lung to advance inhalable vaccine development, and computational
approaches to elucidate the mechanisms by which small molecules regulate the structure and function of virus
capsids.
The goals of the Administrative Core are (1) Development of the administrative, fiscal and scientific aspects of
the proposed COBRE, including establishment of a leadership team and a hiring plan; (2) Implementation of
summative and formative evaluation strategies by the Leadership Team, an Internal Advisory Committee (IAC),
mentors, and an External Advisory Committee (EAC); (3) Implementation of a Career Guidance Plan that
enables faculty to develop successful research programs and to attract funding for their work; (4) Development
of research, training & career development goals and capabilities. A plan for hiring and retaining successful
faculty is detailed as is a plan for transitioning investigators to independent status with continued access to core
facilities and participation in COBRE sponsored events.